Diversity generation in the gastrointestinal microbiome

PROJECT ABSTRACT
Colonization factors that facilitate establishment in the complex and competitive environment of the
gastrointestinal (GI) microbiome are still relatively unknown, but knowledge of these factors will be crucial for
understanding the formation of this ecosystem and reveal novel therapeutic avenues to manipulate this
community. Serving as potential colonization factors, Diversity Generating Retroelements (DGRs) are genetic
elements found in bacteria, archaea, and their viruses that are capable of accelerating evolution by rapidly
diversifying ligand binding proteins to alter their ligand recognition. The GI microbiome is the most enriched
ecosystem for DGRs known to date, but the role of DGRs within the microbiome remains completely unexplored.
Therefore, the overarching goal of this proposal is to understand how DGR-driven genotypic variation contributes
to adaptive bacterial phenotypes in the GI microbiome, especially in response to dynamic shifts in the
environment, such as during colonization or from perturbations to the community. The candidate will use five
carefully selected strains of Bacteroides, each of which contains a similar but non-identical DGR that diversifies
either a pilus tip adhesin or a periplasmic protein. In Aim 1, he will uncover factors that control DGR activity in
Bacteroides spp. In Aim 2, he will characterize the in vivo roles of the diversified proteins and identify other
proteins that functionally interact with these diversified proteins. Lastly, in Aim 3, the candidate will determine
the selective fitness advantages conferred by DGR-directed accelerated protein evolution. These aims require
the application of genetic systems to manipulate Bacteroides genomes, RT-qPCR, genome-wide Tn-insertion
sequencing, tandem mass spectroscopy, deep sequencing, computational methods to measure single
nucleotide variation, and gnotobiotic mouse models. Practical implications of this work include the identification
of DGR-encoded and host-encoded factors that control DGR activity in Bacteroides, characterization of the
functions of Bacteroides diversified proteins, and an understanding of how diversification can be utilized to create
selective fitness advantages in complex microbial communities. Insights derived from this proposal will ultimately
be developed into a toolkit for engineering adaptative colonization systems in beneficial microbes that will
facilitate their efficient engraftment into disrupted microbiomes to reverse the dysbiotic states that are often
associated with diseases such as obesity, inflammatory bowel disease, and cardiovascular disease. Included in
this proposal is a detailed career development plan that outlines a five-year timeline for the candidate that
includes hands-on and didactic training in structural biology, bioinformatics, and ecology and evolution. It also
details a diverse, multidisciplinary, and complementary advisory team, including an experienced primary mentor,
who will guide the candidate in both scientific inquiry and career development. By the conclusion of this award,
a successful transition to independence is anticipated to establish an R01-funded research program using DGR-
driven technologies to engineer microbiomes.

Public health relevance
PROJECT NARRATIVE Factors that promote microbial colonization in complex and dynamic communities such as the human gastrointestinal microbiome are poorly understood, but knowledge of their functions could lead to therapeutic interventions that reverse dysbiotic states. We predict that rapid gene diversifiers, such as Diversity Generating Retroelements (DGRs), provide bacteria with selective fitness advantages through rapid evolution of ligand binding proteins that facilitate colonization within the gut microbiome. By testing this prediction, we expect to generate a toolkit for engineering adaptative systems in beneficial microbes that allow efficient engraftment in the gut microbiome.